Administrative Core

The Administrative Core of the Autism Center of Excellence (ACE) center, Public Health and
Autism Science advancing Equitable Strategies across the life course (PHASES), will
provide structure and coordination of all components: four research projects and three cores.
This coordination will ensure that the PHASES Center at the AJ Drexel Autism Institute (AJDAI)
is more impactful than merely the sum of its parts. The Administrative Core of PHASES has four
specific aims, and 13 objectives within those aims. (1) Provide ongoing scientific and logistical
oversight, support, and evaluation to the PHASES center; (2) Facilitate communication and
coordination among PHASES investigators; (3) Provide administrative, budgetary, and
regulatory oversight and support; and (4) Facilitate two-way communication between PHASES
investigators and community stakeholders. The Core will accomplish these aims via creating
and maintaining a Steering Committee that will meet bimonthly, composed of project and core
leadership; an external advisory committee, building from the AJDAI’s success Leadership
Council; strategic planning to ensure Center activities support the mission and vision of the
PHASES Center; and managing all internal and external communications, reporting, and
bidirectional community engagement. The Administrative Core is well poised to complete these
tasks, capitalizing on the existing infrastructure in the AJDAI, where all Core personnel are
employed. The Administrative Core is also well suited to ensure ongoing synergy with the
Dissemination and Outreach Core and the Data Core, as well as personnel and activities across
the four Projects. All members of the Administrative Core have a history of successful
collaboration with each other.